Modulation of host chromatin dynamics and gene expression by viral biomolecular condensates

Project Summary
This project will use model RNA plant viruses to elucidate the mechanisms used by viruses to target
nucleoli and regulate chromatin dynamics and host gene expression. Specifically, we will investigate how the
p26 protein from Pea enation mosaic virus 2 (PEMV2) modulates host chromatin and gene expression by
undergoing liquid-liquid phase separation (LLPS) and partitioning into the nucleolus. We will perform both Assay
for Transposase-Accessible Chromatin using sequencing (ATAC-seq) and RNA sequencing (RNA-seq)
analyses during infection with wild-type or PEMV2-mutant viruses. These experiments will allow us to determine
the extent to which p26 and PEMV2 influence chromatin accessibility and gene expression. The overarching
objective of this study is to ascertain whether p26 and PEMV2 repress antiviral genes by inducing chromatin
compaction while concurrently enhancing the expression of pro-viral genes by relaxing the surrounding
chromatin. Next, we will utilize 2'-O-methylation sequencing (2OMe-seq) to determine whether p26 disrupts the
function of fibrillarin in the nucleolus to alter the methylation patterns of small nuclear RNAs (snRNAs). Since
disruption of snRNA methylation impacts pre-mRNA splicing, we will investigate whether p26 alters alternative
splicing pathways to alter host protein expression and/or function.
In addition to the research objectives outlined above, this project places a strong emphasis on training
undergraduate researchers to conduct experiments and analyze data using safe and accessible plant virus
systems. To further enhance the impact of this work on the undergraduate student body, the research findings
will be directly incorporated into the undergraduate bioinformatics course at the University of Missouri-Kansas
City (UMKC). This way, >20 students/year will be exposed to hands-on bioinformatics techniques and gain
valuable skills in analyzing real-world data. Overall, this study will provide a comprehensive understanding of
how nucleoli shape virus-host interactions and provide meaningful research experiences for underrepresented
students at UMKC.

Public health relevance
Project Narrative This project aims to investigate the mechanisms by which RNA viruses manipulate chromatin dynamics and gene expression to enhance their replication. By unraveling these molecular processes, we can gain insights into how viruses exploit host cellular machinery, leading to the development of targeted antiviral strategies. Ultimately, this research holds promise for advancing our understanding of viral pathogenesis and improving public health outcomes.